Restrictive and binge eating during adolescence: the role of negative self-related cognitions and social stress

This Mentored Patient-Oriented Research Career Development Award is focused on elucidating neural and
psychosocial mechanisms of eating disorders in adolescence. The research and training plans are designed to
prepare the investigator to conducted independent research in adolescent eating disorders through training in
biobehavioral and psychosocial mechanisms and sophisticated methods for their assessment. Eating disorders
are characterized by high rates of physical and psychiatric morbidity, and adolescence is a developmental
phase in which eating disorders commonly emerge. Negative self-related schema (i.e., low self-esteem) and
poor social functioning are hypothesized to contribute to the onset and/or maintenance of eating disorders by
promoting maladaptive restrictive eating and recurrent binge eating. However, few studies have investigated
these constructs outside the self-report domain, and examinations of direct associations with eating disorder
behavior are limited. Thus, the role of self-related schema and poor social functioning as eating disorder
etiologic and maintenance factors, as well as their utility as treatment targets, remain key empirical gaps. This
K23 aims to address these gaps by testing associations among negative self-related schema, social
functioning, and eating disorder behavior across units of analysis including neurophysiological activity,
phenotypes, and real-time passive monitoring. Participants will include female adolescents aged 14-17 years
with maladaptive restrictive eating (defined by a diagnosis of AN, n = 30), recurrent binge eating (defined as a
diagnosis of bulimia nervosa (BN) or binge eating disorder (BED), n = 30), and healthy controls (n = 30). At
baseline, adolescents will complete a self-referential encoding task while electroencephalography data are
acquired to probe behavioral and neurophysiological processes of self-related schema. To probe real-time
social processes, we will leverage smartphone technology and use a passive sensing application over a 6-
month period to continuously measure key aspects of social functioning—size of social network, frequency of
interactions, and negative content of interactions. Adolescents in the eating disorder groups will complete
ecological momentary assessment 1 week/month for six-months to assess the frequency and intensity of
maladaptive restrictive and binge eating in the natural environment. The following aims will be addressed: First,
we will compare self-related schema and social functioning between adolescents with an eating disorder and
healthy controls (Aim 1). Second, we will test the associations between self-related schema and social
functioning with the frequency and intensity of eating disorder behavior over 6-months (Aim 2). Last, we will
test the interaction between negative self-related schema and social functioning to predict eating disorder
behavior. The current project will elucidate whether self-related schema and social functioning distinguish
adolescents with an eating disorder and are associated with eating disorder behavior. These findings will
inform the utility of these hypothesized mechanisms as treatment targets for adolescents with eating disorders.

Public health relevance
Eating disorders affect 2-5% of women and girls and result in medical and psychiatric morbidity, impairment in quality of life, and in some cases, loss of life. This is a Mentored Patient-Oriented Research Career Development Award that will prepare the investigator to conduct independent research in the field of adolescent eating disorders through training in biopsychosocial mechanisms and sophisticated methods for their assessment. The knowledge gained will help identify new targets for treatment for adolescents with eating disorders.